How do glia remodel the nervous system?

Project Summary
A common feature of nervous systems is that they are initially overpopulated with neurons and over-wired, initially
generating an excessive number of synaptic connections. This is followed by an essential period of remodeling
whereby a subset of extraneous neurons or synaptic connections are removed in order to optimize function in
the adult nervous system. The elimination of cells and pruning of synapses is a process coordinated by neurons
and glia. The selection of specific connections or cells for elimination seems to involve a conversation between
neurons and glia, and the clearance of debris from the nervous system is performed predominantly by phagocytic
glial cells. Previous research has highlighted that the nervous system uses a diversity of molecules and
mechanisms to identify engulfment targets, which appear to be context-specific. However, major gaps still exist
in our knowledge of how neurons identify themselves to be remodeled and how glial cells recognize these dying
or pruning neurons. Studying these processes can potentially lead us to a better understanding of mechanisms
underlying neurodevelopmental disorders such as Autism Spectrum Disorders and Schizophrenia. Our lab has
employed Drosophila as a model system for several reasons including the powerful genetic tools and the
stereotyped nature of one of its remodeling periods—metamorphosis. Through transcriptomic profiling in
phagocytic astrocytes, I identified the transmembrane immunoglobulin superfamily gene borderless. My
preliminary data suggests that Bdl is highly expressed in astrocytes during engulfment periods early in
metamorphosis. Interestingly, loss of both Borderless (Bdl) and the known engulfment receptor Draper (MEGF10
in mammals) resulted in strong suppression of astrocyte engulfment of synapses and neurites. Bdl has been
described to interact with a closely related protein named Turtle, and my preliminary data further suggests Turtle
is specifically localized to neurites and synapses, and excluded from the cell body (the only compartment of the
cell that astrocytes do not engulf). Turtle may therefore act as a molecular tag for astrocytes to recognize
appropriate engulfment targets. In Aim 1 of this study, I will characterize Bdl expression in astrocytes, explore
genetic interactions between Bdl and Draper, and determine which domains of Bdl are essential for engulfment
activity. In Aim 2, I will 1) define genetic interactions between Bdl, Turtle, and Draper, 2) determine the cell
autonomy of Bdl and Turtle in the remodeling of corazonin neurons and 3) determine the subcellular localization
of Turtle positing me to explore Turtle as a molecular tag for specifying neurites for engulfment. My work has the
potential to define two novel components of the astrocytic engulfment machinery, (Bdl and Turtle), explore how
they converge with Draper/MEGF10, and identify Turtle as a neurite/synapse-specific molecular tag that directly
directs astrocyte engulfment activity. This work will significantly advance our understanding of the molecular
basis of neuron-glia signaling during neuronal remodeling, which will be essential for us to understand and treat
neurodevelopmental disorders in humans.

Public health relevance
Project Narrative Neuronal remodeling is a conserved process whereby the developing nervous system eliminates extraneous cells and connections. This refinement allows for proper rewiring of the nervous system for optimal function in adulthood. My goal is to understand the fundamental mechanisms by which unneeded neurons and connections are recognized and appropriately eliminated from the developing nervous system, which holds promise for furthering our understanding of neurodevelopmental disorders such as Autism Spectrum Disorders and Schizophrenia.